Administrative Core (AC)

PROJECT SUMMARY/ABSTRACT
The overall goal of the Administrative Core (AC) is to provide a structure and set of activities that
integrates the science and scientists of the Integrative Omics Center for Accelerating Neurobiological
Understanding of Opioid Addiction (ICAN) to facilitate breakthrough discoveries in the biological drivers of
opioid addiction (OA). The diversity of scientists, omics data, cohorts, species, and analyses are substantial
strengths of ICAN. That diversity is also a challenge. We will systematically meet this challenge through
frequent cross-ICAN interaction, shared milestone setting and evaluation, use of centralized computing and
protocol development in the Synergy Core (SynC), and leveraging collaboration technology. The AC, in
conjunction with the SynC, will create synergy from diversity to collectively achieve ICAN aims and enrich the
community. The AC has the following specific aims:
Aim 1. Establish the Center Steering Committee as a conduit for cross-ICAN communication and
governance.
Aim 2. Establish the External Advisory Board as an active connection to external expertise and
consortia to enhance the science and impact of ICAN.
Aim 3. Set annual milestones and evaluate performance for ICAN, as well as for each Project and
Core.
Aim 4. Leverage sharing technology to enhance investigator interaction and documentation.
Aim 5. Provide education and outreach to the community, facilitating ICAN’s role as a national
resource.